Neuron vasculature interactions in pain

Neuropathic spontaneous pain, a main symptom of neuropathic pain, is often a particularly intractable clinical
problem. While much has been done to understand the sensory sensitization to evoked pain, the mechanisms
underlying neuropathic spontaneous pain are less understood and believed to be different from evoked pain
mechanisms. Our collaborator Dr. Xinzhong Dong’s lab in Johns Hopkins University created Pirt-GCaMP6 mice,
mice in which a genetically encoded Ca²+ indicator GCaMP6 is specifically expressed in >95% of dorsal root
ganglion (DRG) neurons under the control of the Pirt promoter. With these mice, we were able to examine DRG
neuronal activity in vivo, still in its original environment and spatial arrangement. We found that after nerve injury,
spatially clustered neurons with sporadic spontaneous activity formed within the DRG (Zheng et al., Neuron,
2022). Mice that displayed increased spontaneous pain behavior after nerve injury were found to highly correlate
with presence of these ectopic ‘cluster’ neurons. We further discovered that cluster firing of DRG neurons and
neuropathic spontaneous pain could be triggered by sympathetic activation - effects blocked by both α- and β-
adrenergic antagonists. However, the main target of sympathetic activation is not clear since adrenoceptors are
expressed in sensory neurons as well as the blood vessels in the DRGs. Results from our preliminary studies
show that cluster firing and spontaneous pain behaviors are enhanced by local or systemic administration of
vasoconstrictors (e.g., phenylephrine or angiotensin II), and that evoked and spontaneous cluster firing as well
as spontaneous pain are decreased by blocking the Piezo2 mechanoreceptors in the DRG pharmacologically or
genetically. We thus hypothesize that neuropathic spontaneous pain and cluster firing of sensory neurons after
peripheral nerve injury are triggered by the mechanical movement (i.e., vasoconstriction and/or vasodilation,
blood vessel displacement) of the blood vessels within the DRGs. The somata or axons of all neurons in the
clusters are physically associated with branches of blood vessels supplying the DRG. We further hypothesize
that Piezo2 receptors expressed in the majority of hyperexcitable DRG neurons mediate such effects. The
above-mentioned findings that sympathetically evoked cluster firing and spontaneous pain can be blocked by
both α- and β-adrenergic antagonists support our hypothesis since blocking α- and β-adrenoceptors would block
vasoconstriction and vasodilation, respectively, and both would result in stabilization of blood vessel movement.
In this application, using established mouse and rat neuropathic pain models, we propose to test the hypothesis
in 3 Specific Aims (SA). SA1 will characterize the role of local vascular movement in triggering neuropathic
spontaneous pain. SA2 will determine how mechanoreceptors in sensory neurons contribute to vascular
movement-evoked spontaneous pain. SA3 is to identify additional key risk factors for vascular movement-evoked
spontaneous pain. The proposed experiments will investigate a novel mechanism for neuropathic spontaneous
pain and provide a mechanistic basis for developing better therapeutics for this often-intractable clinical problem.

Public health relevance
Project Narrative Chronic pain is a serious problem that affects 1 in 3 Americans and one of its less understood symptoms is spontaneous pain. Our research has shown, after nerve injury, spontaneously active “cluster firing” sensory neurons and neuropathic spontaneous pain can be triggered by local mechanical movement of the blood vessels in the sensory ganglia. Understanding the causal mechanism behind vascular movement-evoked spontaneous pain could help lead to a new understanding about spontaneous pain and possibly to novel treatment targets.